East Africa International Epidemiology Database to evaluate AIDS (IeDEA) Regional Consortium

Project Summary/Abstract:
Our primary goal continues to be the provision of answers to questions that clinicians, governments,
programs and international organizations consider central to the evolution and sustainability of their long term
HIV care and treatment strategies for achieving the UNAIDS 2030 targets of 95-95-95 in the midst of the
SARS-CoV-2 pandemic and changes in public health funding priorities. Our central hypothesis is that
retention in the HIV care cascade and treatment outcomes are influenced by patient-level demographic,
clinical, developmental, and behavioral factors, as well as, factors within the ambient health care and broader
contextual environment. We will leverage our strengths, including robust working relationships with HIV
treatment programs, a substantial harmonized regional database, plus broad experience in sampling-based
methodologies and novel analytical approaches. Over the course of this research we will: SA-1: Describe
movement through the HIV care cascade with a focus on identifying broader and health care environment
contextual factors that influence optimal retention in care and viral suppression, in the face of global disruption
due to the COVID-19 pandemic and changes in donor funding priorities. The Post COVID-19 Double-Sampling
Cohort (Post COVID) will address the impact of broader contextual factors (COVID-19) while the Telehealth
and Structural Adaptations project will address the impact of health care structure. SA-2: Examine the impact
of developmental stage and behavioral factors on retention in the cascade and subsequent outcomes. The
multiregional Adolescent and Young Adult Network of IeDEA (AYANI) and regional Measuring Adverse
Pregnancy and Newborn Congenital Outcomes (MANGO) cohorts will assess the impact of developmental
stage on the cascade, while the Syndemics cohort will address the impact of mental health on the cascade.SA-
3: Examine the immediate and long-term outcomes of people diagnosed with Tuberculosis (TB) with a
focus on identifying and addressing factors associated with patient outcomes. The multiregional TB Sentinel
Research Network (TB-SRN) will focus on understanding TB outcomes and long-term pulmonary
complications including associated factors. SA-4: Explore the use of new technologies, including eHealth
and machine (deep) learning to diagnose and manage HIV-associated cancers with a focus on Kaposi’s
Sarcoma (KS) and Cervical Cancer. The KS Project will assess implementation of a Dermatology Telehealth
Program and the Cervical Cancer Project will assess the implementation of cervical image capture with
machine learning for cancer diagnoses and management. SA-5: Examine the epidemiology of NCD
comorbidities and ART complications with a focus on the oldest and youngest-age groups affected by HIV.
The multi-regional Sentinel Research Network (SRN) will address non-communicable diseases in people living
with HIV (PLHIV) > 40 years and the regional MANGO Cohort will address complications of ART/HIV exposure
on HIV-Exposed Infants.

Public health relevance
Project Narrative: Through our efforts, we will enhance our understanding of the HIV care cascades and the outcomes of care in East Africa, provide insights on the optimal structure and impact of care and treatment programs, expand the set of tools available to inform implementation and operations research in resource-constrained settings and inform policy among stakeholders and decision makers at every level in the region as well as the broader HIV/AIDS scientific community.